CRCNS: Avian Model for Neural Activity Driven Speech Prostheses

Understanding the physical, computational, and theoretical bases of human vocal communication, speech,
is crucial to improved comprehension of voice, speech and language diseases and disorders, and
improving their diagnosis, treatment and prevention. Meeting this challenge requires knowledge of the
neural and sensorimotor mechanisms of vocal motor control. Our project will directly investigate the neural
and sensorimotor mechanisms involved in the production of complex, natural, vocal communication
signals. Our results will directly enhance brain-computer interface technology for communication and will
accelerate the development of prostheses and other assistive technologies for individuals with
communications deficits due to injury or disease. We will develop a vocal prosthetic that directly translates
neural signals in cortical sensorimotor and vocal-motor control regions into vocal communication signals
output in real-time. Building on success using non-human primates for brain computer interfaces for
general motor control, the prosthetic will be developed in songbirds, whose acoustically rich, learned
vocalizations share many features with human speech. Because the songbird vocal apparatus is
functipnally and anatomically similar to the human larynx, and the cortical regions that control it are closely
analogous to speech motor-control areas of the human brain, songbirds offer an ideal model for the
proposed studies. Beyond the application of our work to human voice and speech, development of the
vocal prosthetic will enable novel speech-relevant studies in the songbird model that can reveal
fundamental mechanisms of vocal learning and production. In the first stage of the project, we collect a
large data set of simultaneously recorded neural activity and vocalizations. In stage two, we will apply
machine learning and artificial intelligence techniques to develop algorithms that map neural recordings to
vocal output and enable us to estimate intended vocalizations directly from neural data. In stage three, we
will develop computing infrastructure to run these algorithms in real-time, predicting intended vocalizations
from neural activity as the animal is actively producing these vocalizations. In stage four, we will test the
effectiveness of the prosthetic by substituting the bird's own vocalization with the output from our prosthetic
system. Success will set the stage for testing of these technologies in humans and translation to multiple
assistive devices. In addition to our research goals, the project will engage graduate, undergraduate, and
high school students through the development of novel educational modules that introduce students to
brain machine interface and multidisciplinary studies that span engineering and the basic sciences.
RELEVANCE (See instructions):
Developing a vocal prosthesis will directly enhance brain-computer interface technology for communication
and accelerate the realization of prostheses and other assistive technologies for individuals with
communications deficits due to injury or disease. The basic knowledge of the neural and sensorimotor
mechanisms of vocal motor control acquired will impact understanding of multiple voice, speech, and
language diseases and disorders. The techniques developed will enabling novel future studies of vocal
production and development.